Shedding Light on Glaucoma: Next Generation of Optogenetics for Aqueous Outflow Regulation

,!5#/-! ! ,%!$).' #!53% /& )22%6%23)",% ",).$.%33 ). 4(% 7/2,$ !&&%#43 -/2% 4(!. 6%4%2!.3
,%6!4%$ ).42!/#5,!2 02%3352% )3 !33/#)!4%$ 7)4( "/4( $%6%,/0-%.4 !.$ 02/'2%33)/. /& 02)-!29 /0%.
!.',% ',!5#/-! !.$ )3 4(% /.,9 -/$)&)!",% 2)3+ &!#4/2 &/2 4(% $)3%!3% /7%6%2 4(% -%#(!.)3-3 #!53).'
%,%6!4%$ 2%-!). 0//2,9 5.$%234//$ 2!"%#5,!2 -%3(7/2+ #%,,3 !2% #2)4)#!, 4/ -!).4!).).' ! ./2-!,
!15%/53 &,5)$ &,/7 !.$ . /4(%2 4)335%3 35#( !3 4(% +)$.%9 "/.%3 !.$ #!24),!'% 4(% 02)-!29 #),)! 0,!9 !
-%#(!./3%.3/29 2/,% ). &,5)$ &,/7 %2% 7% 7),, %80,/2% 4(% 0/4%.4)!, /& #),)! ). 42!"%#5,!2 -%3(7/2+ #%,,3 4/
3%26% ! -%#(!./3%.3/29 2/,% ). 4(% %9% . /52 02%6)/53 &5.$).' #9#,% 7% $%-/.342!4%$ 4(!4 0(/30(/)./3)4)$%
,)0)$3 7)4(). 02)-!29 #),)! !2% !. )-0/24!.4 2%'5,!4/2 /& %9% 02%3352% % 3(/7%$ 4(!4 0(/30(/)./3)4)$% ,)0)$3
7)4(). 02)-!29 #),)! !2% 4)'(4,9 #/.42/,%$ !.$ 4(!4 $932%'5,!4)/. 02/$5#%3 %,%6!4%$ %9% 02%3352% 3).'
/04/'%.%4)# 4%#(.)15%3 7% 4!2'%4%$ $%,)6%29 /& )./3)4/, %.:9-%3 4/ 35"#/-0!24-%.43 7)4(). 42!"%#5,!2
-%3(7/2+ #%,,3 4/ $%-/.342!4% 4(%)2 &5.#4)/. ). 2%'5,!4).' 54!4)/.3 ). !. )./3)4/, 0/,90(/30(!4%
0(/30(!4!3% #!53% #/.'%.)4!, ',!5#/-! % &524(%2 )$%.4)&)%$ ! ./6%, ,).+ "%47%%. 3)'.!,).' "9 #),)!
0(/30(/)./3)4)$%3 !.$ !54/0(!'9 !.$ ,93/3/-!, &5.#4)/. %2% 7% "5),$ /. /52 342/.' 02%,)-).!29 %6)$%.#% /&
4(% 0/7%2 /& /04/'%.%4)# 4//,3 4/ $%6%,/0 ! .%7 /04/'%.%4)# 2%'5,!4/2 &/2 %9% 02%3352% "!3%$ /. 04/ ;
#()-%2)# 02/4%). #/50,%$ 2%#%04/2 4(!4 (!3 "%%. 3(/7. 4/ 34)-5,!4% /54&,/7 &!#),)49 % (90/4(%3):%
4(!4 /04/'%.%4)#!,,9 2%'5,!4%$ !.$ 0(/30(/)./3)4)$% 3)'.!,).' 7)4(). 42!"%#5,!2 -%3(7/2+ #%,,3 7),,
34)-5,!4% !15%/53 /54&,/7 . )- 7% 7),, $%4%2-).% 7(%4(%2 2%$5#4)/. /& "9 !'/.)34
$%0%.$3 /. 02)-!29 #),)! 3)'.!,).' . )- 7% 7),, $%4%2-).% 7(%4(%2 #()-%2)# 04/ 7),,
)-02/6% /54&,/7 &!#),)49 . )- 7% 7),, $%4%2-).% 7(%4(%2 ,%6%,3 !2% 2%$5#%$ ). 42!"%#5,!2 -%3(7/2+
/& /0%. !.',% ',!5#/-! 0!4)%.43 (% 02/0/3%$ 2%3%!2#( )3 %80%#4%$ 4/ (!6% ! 3)'.)&)#!.4 )-0!#4 /. 4(%
5.$%234!.$).' /& -%#(!./3%.3!4)/. /& %9% 02%3352% ). -!--!,3 7()#( 7),, &!#),)4!4% 4(% $)3#/6%29 /& .%7
4(%2!0)%3 &/2 /0%. !.',% ',!5#/-! !.$ /4(%2 &/2-3 /& ',!5#/-! ,4)-!4%,9 4(% +./7,%$'% /"4!).%$ &2/- 4()3
02/*%#4 7),, ,%!$ 4/ ./6%, 4(%2!0%54)# #/-0/5.$3 &/2 4(% -!.9 6%4%2!.3 35&&%2).' &2/- 6)3)/. ,/33

Public health relevance
NARRATIVE Glaucoma is a leading cause of irreversible blindness in the world, and affects over 285,000 US veterans. Lowering eye pressure remains the only treatment for glaucoma, yet the mechanisms of eye pressure regulation remain unknown. In this application, we will utilize our previous findings and preliminary data to develop a next-generation light-regulated switch that will decrease eye pressure in a mouse model of glaucoma. This optogenetic approach is significant because it will better define regulatory elements that control eye pressure and may also provide a new approach to reset eye pressure in the clinic by simply shining a light into the eyes. We anticipate that this research will ultimately lead to new treatments for VA patients with glaucoma.